Investigation of acute and long-term neuroimmune changes induced by early-life opioid exposure and withdrawal

Project Summary/Abstract
Opioid use has increased drastically among all demographics in the United States, including in pregnant
women. This rise opioid use during pregnancy leads to health concerns for infants, who may develop acute
opioid withdrawal symptoms shortly after birth, resulting in a diagnosis of Neonatal Opioid Withdrawal
Syndrome (NOWS). There is no standard of treatment for NOWS, though some hospitals choose to treat using
morphine tapering or buprenorphine. Despite increasing rates of diagnoses, the long-term effects of NOWS on
cellular function, physiological development, and behavior have yet to be fully characterized. Opioids are
modulators of the immune system and exert pro-inflammatory effects within the central nervous system by
binding to microglia. Clinical data has shown potential immune dysfunction in infants diagnosed with NOWS,
but these studies are limited, and results have not yet been fully examined in preclinical models. Using a novel
mouse model of NOWS (“the three-trimester model”), we have found evidence of increased microglia levels
induced by perinatal opioid exposure immediately after withdrawal. The full extent of this neuroimmune
dysfunction, as well as the long-term changes, have yet to be studied. The goal of this proposal is to fully
characterize the acute and persisting neuroimmune changes induced by early life opioid exposure and
withdrawal, and to evaluate microglia as a potential therapeutic target in mitigating withdrawal symptoms. Aim
1 will investigate acute changes in microglia and cytokines immediately following opioid withdrawal at postnatal
day 15. Aim 2 will measure persisting neuroimmune alterations in adulthood, both at baseline and in response
to an immune challenge, by examining molecular changes and sickness response behavior. Aim 3 will
pharmacologically suppress microglial activation and assess for improvements in withdrawal symptoms.
Successful completion of these aims will fully characterize neuroimmune changes induced by perinatal opioid
exposure and withdrawal and provide evidence for a novel therapeutic target in treating NOWS. Through this
fellowship, Ms. Ferrante will accomplish defined Training Goals, including technical proficiency in molecular
laboratory techniques, expertise in the field of neuroimmunology, refined written and oral scientific
communication, and professional development towards a career in academic research. This fellowship will also
facilitate progress towards achieving her current and future research goals in order to enable success as an
independent researcher.

Public health relevance
Project Narrative The number of infants diagnosed with Neonatal Opioid Withdrawal Syndrome (NOWS) continues to rise, though the full extent of long-term molecular and behavioral changes induced by NOWS is still unknown. Opioids are known modulators of the immune system, and clinical data supports immune dysfunction in patients previously diagnosed with NOWS. This proposal aims to fully characterize the molecular and behavioral manifestations of neuroimmune alterations induced by NOWS, and to investigate the novel pharmacologic application of a microglial-targeting drug in treating symptomology.